Mechanisms of gene regulation in bacterial defense islands

PROJECT SUMMARY
Mechanisms of gene regulation in bacterial defense islands
Advancements in bioinformatics and the availability of tens of thousands of bacterial genome sequences
have enabled the discovery of diverse pathways in bacteria that defend against environmental stress and
bacteriophage (phage) infection. Over 100 different antiphage immune systems have been identified, and each
bacterial genome encodes a different combination of ~5-20 such systems. Over the past five years, the
molecular mechanisms of many antiphage immune systems have been deciphered, but because immune
systems are typically studied one-by-one in model organisms, how these systems are regulated in their native
hosts is not well understood. Our lab previously identified the transcriptional regulators CapH+CapP and
CapW, which are each associated with diverse antiphage immune systems and control their expression in
response to phage infection and/or DNA damage. Our fortuitous discovery of CapH+CapP and CapW implies
that many similar regulators remain to be discovered. The aim of my research is to identify and characterize
novel transcriptional regulators associated with antiphage immune systems in clinically-important bacterial
pathogens. While studying ubiquitination-related BilABCD and BubABCD systems, I identified the novel
transcriptional regulators CapK and CapS, and further found that these proteins co-occur with a variety of
antiphage immune systems. I will define the upstream signal(s) and molecular mechanisms of CapK+CapS,
thereby expanding our knowledge of how bacteria respond to phage infection. Building off my work on
CapK+CapS, I will perform comprehensive bioinformatics searches of bacterial genomes to identify new
immune system-associated transcriptional regulators, then use my established experimental workflow to
validate their activity and define their molecular mechanisms. Complementing this work, I will perform gene
expression profiling (RNA-Seq) on a large panel of clinical Enterobacter isolates with distinct sets of antiphage
immune systems, to determine whether and how these systems are regulated in response to phage infection,
DNA damage, and other stress. This work will define the global transcriptional control networks that regulate
expression of antiphage immune systems and coordinate the bacterial response to infection. Together, the
work proposed here will comprehensively define the mechanisms of transcriptional regulation in antiphage
immune systems, and establish gene expression regulation as a widespread means of bacterial immune
system control.

Public health relevance
PROJECT NARRATIVE Bacteria encode diverse immune systems that protect their host from infection by bacteriophages, but whether and how these systems are regulated at the gene expression level is not well understood. I will comprehensively identify and define the transcriptional regulators that control bacterial immune systems in response to phage infection and other environmental stresses including DNA damage. This work will result in a more complete understanding of how bacteria respond to bacteriophage infections, thereby aiding the development of effective bacteriophage therapies to address the rise in multidrug-resistant bacterial pathogens.